CIGARETTE SMOKING TOPOGRAPHY AMONG AFRICAN AMERICAN AND CAUCASIAN WOMEN

This describes smoking topography by race (black or white) and menthol or nonmenthol use to determine if these factors are related to nicotine metabolites.